Multilevel Barriers and Facilitators to Addressing Disparities in Perinatal Mental Health

ABSTRACT
Black perinatal women face significant mental health disparities. In particular, Black women are at increased
risk for trauma and stressor-related disorders, which have been shown to be associated with significantly
increased risk for severe maternal morbidity. Few Obstetric departments screen patients for trauma and
stressor-related disorders, and Black women are less likely to be insured and have access to perinatal care. To
begin to address disparities in unmet trauma and stress needs among Black perinatal women, we propose a
sequential mixed-method study with three aims: (1) utilizing data from the National Survey on Drug Use and
Health (NSDUH), identify determinants of mental health treatment utilization and unmet mental health needs
among a national sample of Black women of reproductive age (18-44 years) with serious psychological
distress; (2) to contextualize findings from Aim 1, use the patient-centered access framework to analyze data
from 5 focus groups with Black perinatal women living in two urban areas (n=40) to understand barriers and
facilitators to accessing perinatal mental health supports and recommendations to improve access; and (3)
conduct semi-structured interviews with 20 OB providers and administrators from two urban, safety-net hospital
systems serving primarily Black patient populations to assess provider and systems-level barriers and
facilitators to conducting trauma and stressor-related disorder screenings and referrals. Achieving the aims of
this study will lead to the identification of multilevel barriers and facilitators to addressing unmet mental health
needs among Black perinatal women who experience trauma and stress. By utilizing a mixed-methods
approach that integrates national estimates with contextualized patient, provider, and administrator
perspectives, this study will generate targeted policy and program-based recommendations to promote access
to trauma and stressor-related disorder screenings and services for Black perinatal women in order to reduce
disparities in maternal morbidity.

Public health relevance
PROJECT NARRATIVE Trauma and stressor-related disorders are associated with severe maternal morbidity, yet trauma related screening and services remain extremely rare in obstetric settings. In particular, Black perinatal women are known to face disproportionate rates of trauma and stressor-related disorders and also report significant structural barriers to accessing care. This sequential, mixed-methods study will combine national estimates with qualitative perspectives from Black perinatal women and Obstetric providers and administrators to identify multilevel barriers and facilitators to caring for the mental health of Black perinatal women experiencing trauma and stress in order to develop targeted recommendations for future implementation of culturally responsive trauma screening and referrals.